MAQFACS: MEASURING FACIAL MOVEMENT IN RHESUS MONKEYS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is a project to develop an objective coding system for measuring facial movement in rhesus monkeys involving a subcontract with University of Arizona Tucson. There are 3 main components. Our first objective is to stimulate the facial muscles of rhesus monkeys to verify the actions resulting from specific muscle contraction. Next, we will perform dissections of rhesus monkey facial muscles to validate the presence and general configuration of these muscles. Finally, we will verify the range of facial movements occurring naturally in this species from video and develop the MaqFACS coding system. The first two aims have been completed and the last aim is in its final stages.